ENERGY EXPENDITURE IN HEALTHY CHILDREN AND CHILDREN WITH RETT SYNDROME

It is the hypothesis of this project that growth failure in children with Rett Syndrome can be shown to be nutritionally-mediated, particularly with respect to dietary energy, based on clinical features of the disease, e.g., feeding difficulties and increased energy expenditure due to repetitive motor activities.